Enhanced auditory prosthesis using a penetrating auditory-nerve electrode

1. Project Summary. This project aims to improve hearing restoration for severely and profoundly deaf
people. The present-day standard of care for restoration of hearing is a cochlear implant (CI), consisting of 16-
22 metal electrodes inserted into the scala tympani of the cochlea. Most CI users can expect to achieve
reasonable speech reception in quiet environments. Performance is unsatisfactory, however, in everyday
complex auditory scenes containing background noise and competing talkers, as in restaurants and in busy
offices and classrooms. Also, CI users have only limited sensitivity to cycle-by-cycle temporal fine structure of
sounds, which underlies temporal pitch perception. The impaired pitch perception exacerbates the problems of
hearing in complex scenes, impairs voice recognition and sensitivity to the emotional content of speech, limits
music appreciation, and degrades understanding of Mandarin and other tonal languages. We have shown in
short-term studies in anesthetized cats that a penetrating intraneural (IN) electrode array inserted into the
cochlear nerve can overcome many limitations of a CI. In particular, an IN electrode can selectively activate
low-frequency cochlear and brainstem pathways that are specialized for transmission of temporal fine
structure information. We now wish to translate IN stimulation to human trials. Specifically, we propose to test
the feasibility of an implanted prosthesis; our working name for the device is “CI+1”. The CI+1 consists of 15
channels of a 16-channel Advanced Bionics CI combined with a single-channel iridium electrode that will
penetrate the cochlear nerve to target low-frequency cochlear nerve fibers. The iridium electrode is equivalent
to one shank of the 8-10 shank penetrating auditory brainstem implant that has been used in FDA-approved
clinical trials. Specific Aim 1 is to test the safety and efficacy of 6-month implantations of the CI+ 1 in cats, with
daily stimulation. We will measure the electrically evoked auditory brainstem response (eABR) at 2-wk
intervals to track any changes in stimulation threshold. Then, in a terminal experiment involving recordings
along the tonotopic axis of the inferior colliculus, we will assess spread of excitation and transmission of
temporal information by the intrascalar and IN electrodes. Specific Aim 2 is to evaluate short-term IN
stimulation in human patients who are undergoing surgery to resect vestibular schwannomas. Specific Aim 3 is
to evaluate optimal surgical approaches for CI+1 implantation using studies of cadaveric human temporal
bones. Early in the 5th year of funding, we aim to have completed the necessary background studies and to
apply for an investigational device exemption from the FDA that will permit translation of the CI+1 to the first
human trials. We anticipate that the CI+1 will offer the first human volunteers essentially all the benefits of a
conventional CI plus enhanced sensitivity to low-frequency sounds and enhanced pitch perception. In clinical
applications, the CI+1 might initially be favored for certain applications, but in principle the device would be a
preferred alternative for nearly every candidate for cochlear implantation.

Public health relevance
2. Project Narrative Present-day cochlear implants can offer reasonable speech reception in quiet environments, but implant users struggle to understand speakers in the presence of competing sounds, in large part because of their insensitivity to the cycle-by-cycle timing of sounds. We will test an enhancement of the cochlear implant consisting of a penetrating electrode that will target auditory nerve fibers that project to low-frequency pathways that are specialized for transmission of low-frequency timing information. The experimental design consists of animal and human experiments intended to support an application for the investigational device exemption (IDE) needed for the first human trials.